Senescent periodontal ligament cells as a potential therapeutic target for age-associated periodontitis

Project Summary/Abstract
Periodontal disease (PD) is a leading cause of tooth loss in adults. The mechanisms by which aging increases
PD bone loss are unknown. Treating PD costs $3.49B in the US in 2018, and socio-economic burden of PD is
projected to increase. Thus, there is an urgent need to develop therapeutics to overcome PD. Excess bone
resorption and reduced bone formation are mechanisms of PD bone loss. In young mice, we showed that
ligature-induced PD (LIP) caused transient bone resorption followed by bone formation, resulting in limited LIP
bone loss. Conversely, we found that while resorptive patterns were similar in mature mice, bone loss in LIP
could not be recovered due to impaired bone formation, suggesting that reduced osteogenic capability with
age is a mechanism for increased PD bone loss in adults. Previous studies demonstrated that aging in
osteoprogenitors reduced bone formation in long bones. However, this mechanism has not yet been tested in
the osteoprogenitors in periodontal ligaments (PDLs), the major source of periodontal osteoprogenitors. Cellular
senescence is a driver of aging. Senescent cells (SCs) are induced by biological stresses and persist in tissue
via upregulation of senescent cell antiapoptotic pathways (SCAPs). Accumulation of SCs causes depletion of
tissue progenitors and defective tissue regeneration. Genetic ablation of SCs improved bone formation and
bone mass in aged mice, demonstrating that senolysis could be a therapeutic approach for age-associated
bone loss. We identified SCs in PDLs of mature mice. However, whether removing PDL SCs could prevent
age-associated PD bone loss has yet to be addressed. Pharmacological removal of SCs using senolytics,
drugs that suppress SCAPs, has been proposed to alleviate the negative impacts of SCs. The efficacy of
varying senolytic treatments varies between tissues because of heterogeneity in active SCAPs. We tested
senolytic efficacy in mouse periodontal tissue and support the notion that identifying appropriate senolytic
drugs is crucial to treating a specific disease by senolytics. The senolytics effective for human PDL cells
(hPDLCs) have not yet been identified. We hypothesize that aging in PDLs diminishes alveolar bone recovery
through senescence-mediated functional defects in osteoprogenitors, and removing SCs from PDLs will be an
effective therapeutic approach to reverse the aging effect and protect alveolar bone from age-associated PD
bone loss. We propose the following aims: Aim 1. Determine whether premature aging in PDLs decreases
alveolar bone recovery from PD bone loss. We will genetically induce premature aging in PDLs of young mice
(Plap1-CreERT2/Zmpste24fl/fl) and analyze its impact on periodontal osteogenesis. Aim 2. Determine if PDL-
targeted senolysis restores decreased bone recovery in mature mice. We will ablate SCs in PDLs of mature
mice by inducing SC apoptosis (Plap1-CreERT2/p16INK-LOX-ATTAC) and test the impact of the senolysis on
periodontal osteogenesis. Aim 3. Identify senolytic drug(s) effective for senescent hPDLCs. We will treat
senescent hPDLCs with senolytics targeting varied SCAPs to identify senolytic(s) effective for hPDLCs.

Public health relevance
Project Narrative This project is relevant to public health in that it will elucidate the mechanism of age-associated alveolar bone loss in periodontal disease and propose new therapeutics for the disease. Outcomes from the project will add a new alternative treatment strategy to conventional treatment to prevent tooth loss by periodontal disease. Furthermore, the outcomes will be a foundation to develop a new public health strategy for the prevention of tooth loss.